Administrative Core - Telehealth Research and Innovation for Veterans with Cancer (THRIVE)

SUMMARY Telehealth Research and Innovation for Veterans with Cancer (THRIVE) will use the entire Veterans Health Administration (VA) health care system as our Clinical Practice Network. The overarching goal of the Administrative Core is to ensure the smooth functioning of each aspect of THRIVE and the seamless integration of its components. Specifically, the function of the Administrative Core breaks down into five aims: (1) Project management – The Administrative Core will provide centralized project management and research assistance for all THRIVE projects including the Pragmatic Trial, the Research and Methods Core, Pilot Studies and the Clinical Practice Network. Project management responsibilities will include hiring and management of project staff; project work plan development and management; monitoring initial and renewal submissions to the IRBs; oversight of the Data and Safety Monitoring Plan; scheduling and meeting management; and communication across projects and externally. (2) Scientific planning and integration – The Administrative Core will lead the timing and roll-out of the Pragmatic Trial and pilot studies, as well as coordination and integration across projects and THRIVE components. It will also coordinate feedback from the national External Advisory Board and coordinate an Annual Project Meeting. (3) Fiscal management – THRIVE will take place within a national health system and will involve several consortium agreements. The Administrative Core will manage all Center budgets and oversee the Consortium Agreements, as well as monitoring compliance with fiscal regulations. (4) Training – The Administrative Core will oversee training and mentoring of junior faculty in research on virtual care and oncology. (5) Dissemination – In conjunction with the Research and Methods Core, the Administrative Core will oversee dissemination of Center results and deliverables to both internal and external stakeholders.